Career Enhancement Core

CEC: Project Summary
The CEC component of the Colorado SCORE (CO-SCORE) is focused on providing career enhancement for
researchers in the innovative, growing field of women's health and sex differences research. The Objectives of
the CEC are to 1) develop and support a cadre of accomplished junior researchers in the thematic focus of the
Co-SCORE, Bioenergetic and Metabolic Consequences of the Loss of Gonadal Function; and 2) provide a
curriculum that meets the career enhancement needs of postdoctoral research fellows and junior faculty
scientists focused on translational science in the study of women's health and sex differences. Objective 1 will
be carried out by selecting SCORE Scholars through peer review who are dedicated to developing a career in
women's health or sex differences research. The SCORE Scholars will receive salary support to protect time
for research and funds for research project support. In addition, meritorious pilot projects, selected through
peer review, will be awarded to 3 promising scientists each year. For Objective 2, SCORE Scholars and Pilot
Awardees will participate in an innovative career enhancement program, including team mentoring, hands-on
research experience, and curricular training in academic skills and career development skills. Trainees will
also participate in a summer course featuring relevant topics in endocrinology and receive training in methods
and strategies for studying sex as a biological variable (SABV), which is being developed by the SCORE
faculty. SCORE Scholars and Pilot Awardees will undergo training with the Scholars in the Building
Interdisciplinary Research Careers in Women's Health (BIRCWH) K12, Colorado Clinical & Translational
Sciences Institute (CCTSI), and the Center for Women's Health Research (CWHR). Training activities will be
provided at the CWHR. Dr. Regensteiner, the CORE Leader, is the Director of the CWHR and PI of the
BIRCWH grant, and has led the development of the academic and career development skills curricula that will
be utilized in the CO-SCORE. The mentoring, research experience, and curricular training provided by this
program will provide pivotal support for the SCORE Scholar and Pilot Awardees as they develop careers in
women's health and sex differences research. Expanding the workforce in this area is critical to the field
becoming fully realized. Success in this endeavor means that health and disease in women and men will be
optimally studied so that medical research benefits everyone to the highest level possible.

Public health relevance
CEC: Project Narrative The Career Enhancement Core (CEC) will focus on training junior scientists who want to focus their research in the important areas of sex differences and women's health. Success in this endeavor means that health and disease in women and men will be optimally studied so that medical research is benefiting everyone to the highest level possible. The CEC will provide team mentoring, hands-on research experience, and training in academic and career development skills to expand and prepare scientists who will serve these important goals.